SPORE in Cervical Cancer

This competitive renewal application for a Specialized Program of Research Excellence (SPORE) in Cervical Cancer at the Johns Hopkins University School of Medicine, University of Alabama at Birmingham and University of Colorado brings together a highly interactive, multidisciplinary, and inter-institutional program of translational research in cervical cancer. The SPORE includes four integrated projects spanning the fields of prevention and treatment of cervical cancer. Project I: L1 Capsomeres as a Next Generation Preventive HPV Vaccine, led by Robert Garcea, M.D., Richard Roden, Ph.D., and Warner Huh, M.D. Project II: Development of a Pan-Oncogenic HPV Preventive Vaccine, led by Richard Roden, Ph.D., and Warner Huh, M.D. Project III;A phase I clinical trial to assess the immunogenicity, safety, tolerability and efficacy of HPV DNA-Vaccinia prime booster vaccination with locally applied TLR agonists in patients with HPV-16+ cervical intraepithelial neoplasia 3 (CIN3), led by Cornelia Trimble, M.D., Drew Pardoll, M.D., Ph.D. and T.-C. Wu, M.D., Ph.D. Project IV: A phase I clinical trial to assess the safety and immunogenicity of repeated, cluster particle-mediated epidermal delivery (PMED) of the DNA vaccine, pNGVL4a-CRT-E7(detox), in patients with operable Stage IB1 cervical cancer associated with HPV-16, led by Ronald Alvarez, M.D., Connie Trimble, M.D. and T.-C. Wu, M.D., Ph.D. These four projects are supported by four Cores that provide critical and supportive infrastructure essential to efficient and effective translational research. The Administration/ Communication Core (Core A) led by T. C. Wu, M.D., Ph.D. and Edward Partridge, M.D, the Biostatistics/ Data Management Core (Core B) led by Mei-Cheng Wang, Ph.D., and Sreelatha Meleth, Ph.D., the Tissue /Pathology Core (Core C) led by Brigitte Ronnett, M.D. and Lawrence Lamb, Ph.D. and the Immunology Core (Core D) led by Raphael Viscidi, M.D. and Chien-Fu Hung, Ph.D. The SPORE also includes a Developmental Research Program for rapid funding of novel research ideas and a Career Development Program to facilitate career development of individuals with interest in translational cervical cancer research.

Public health relevance
The intent of our program is to reduce the incidence of cervical cancer and to improve the outcome in patients with HPV associated cervical cancer and their precursor lesions by developing innovative vaccination strategies for the prevention and treatment of cervical cancer.